Quantifying the role of myocyte ultrastructure in atrial health and disease

PROJECT SUMMARY: Atrial fibrillation (AF) is the most common cardiac arrhythmia (affecting ~1-2% of the
general population), resulting in markedly reduced quality of life and increased mortality, due to a combination
of altered hemodynamics, progressive atrial and ventricular dysfunction, and embolic stroke. Many diseases and
conditions, like heart failure, are known to contribute to pathological changes leading to AF. Limitations in current
therapy allow AF paroxysms to progress to persistent and chronic AF, as a result of extensive atrial structural
and electrical changes that facilitate AF maintenance (“AF begets AF”). The development of urgently needed
new strategies for AF treatment hinges upon improved understanding of how abnormalities in cellular function
trigger and sustain arrhythmia in atrial tissue. At the cellular level, a hallmark structural change of many chronic
cardiac diseases is degradation of the intricate membrane architecture that couples cardiac electrical excitation
to intracellular Ca2+ release and myocardial contraction (EC coupling) – i.e., the transverse tubule (TT) structures,
which project orthogonally from the cell surface to its interior and thereby synchronize EC coupling throughout
the cell. Degradation of the TT architecture is generally associated with arrhythmia, but it is not yet clear whether
TT loss is a direct contributor to arrhythmia, a compensatory maladaptation, or an epiphenomenon. This is even
less clear in atria, as atrial myocytes exhibit a vastly variable range of TT architectures, with prominent axial
tubules. Further, TT degradation induced by the process of isolating atrial myocytes (vs. denser TTs in intact
tissues) and challenges in experimentally detubulating intact cardiac tissue has so far limited the design of
mechanistic myocyte and tissue studies. As a result, the literature surrounding the role of subcellular structural
(ultrastructural) remodeling in AF has remained fractured, and currently we know relatively little about its role in
contributing to AF pathophysiology. The overarching goal of this proposal is to discriminate the role of changes
in atrial myocyte ultrastructure from other disease-associated sequelae by combining detailed multi-level
experimental analyses of rabbit atrial myocytes and rabbit and human atrial tissues with extensive quantitative
multi-scale computational modeling. The project will develop and validate a suite of modeling tools used to
investigate the mechanisms by which: (1) naturally occurring variations in atrial TTs influence EC coupling and
membrane stability in isolated atrial myocytes; (2) tissue gradients in TT organization influence tissue-level
electrophysiological and EC coupling outcomes; (3) ultrastructural remodeling synergizes with ionic remodeling
to favor atrial arrhythmogenesis in atrial cardiomyopathy. We contend that quantifying the role of atrial
ultrastructure in AF pathology may shed new mechanistic insight into AF management. Each aim includes
rigorously generated and validated modeling frameworks, informed by novel experiments in atrial myocytes and
tissues, and testing of specific hypotheses. Models and data will be distributed freely and widely via software
and database infrastructure supported by Dr. Grandi's lab and scientific networking sites.

Public health relevance
PROJECT NARRATIVE: Atrial fibrillation (AF), the most common cardiac arrhythmia, affects about ~1-2% of the general population. A complex, progressive disease, it sharply increases the risk of stroke and often coexists with and worsens other severe cardiac diseases, particularly heart failure. This project aims to achieve a better understanding of the mechanisms underlying AF via new research tools, including state-of-the-art computer models, which will ultimately lead to improved treatments and outcomes for patients.